Development of quantitative bone marrow magnetic resonance imaging biomarkers to assess efficacy of novel molecularly targeted agents for myelofibrosis

PROJECT SUMMARY/ABSTRACT
Myelofibrosis is a chronic, ultimately fatal neoplasm caused by malignant hematopoietic stem cells. Pathologic
expansion of blood cells, debilitating constitutional symptoms, massive enlargement of liver and spleen due to
extramedullary hematopoiesis (formation of blood cells in organs other than bone marrow) and progressive
fibrosis of bone marrow are common in patients with MF. Monitoring of treatment response currently relies on
spleen volume by physical examination or imaging. However, limitations of spleen size include treatment
response metric changes are very slow (6-12 months). Assessment of MF patients using bone marrow
biopsy/aspiration, a painful, invasive test which samples only a single site in the iliac crest. Current use of
biopsies and spleen size changes cannot evaluate skeletal marrow-specific heterogeneity or treatment
associated changes as a treatment response metric. MF is a systemic disease thus analyzing a single bone
marrow site provides limited information about overall disease status and response to therapy and blood tests
only provide for a global assessment of disease and have been shown to be of limited utility as predictors of
treatment efficacy. We propose development of an novel MRI diagnostic noninvasive imaging signature to
monitor bone marrow changes to serve as a transformational improvement in patient management. Advanced
specialized MRI sequences and image analysis metrics will be applied to capture key aspects of bone marrow
disease phenotypes in MF mouse models. Quantitative Dixon technique for monitoring changes in proportions
of fat and hematopoietic cells in bone marrow (PDFF) will be used along with diffusion-weighted imaging (DWI),
quantified as apparent diffusion coefficient (ADC) for cellularity changes along with magnetization transfer
imaging (MTR) for detection of changes in macromolecular fibrotic structures. Image processing approaches will
be employed using voxel-by-voxel alignment (i.e., parametric response mapping) to enhance MR image
sensitivity for detection of disease phenotypes and treatment response to develop a robust, multiparametric
diagnostic biomarker. Primary driver mutations in MF converge on constitutive activation of the JAK pathway
resulting in progressive fibrosis with disruption of bone marrow architecture along with massive enlargement of
liver and spleen due to extramedullary hematopoiesis (formation of blood cells in organs other than bone
marrow). As currently approved JAK2 inhibitors do not provide for long-term remission in patients and offer
modest if any, disease-modifying effects, we propose new urgently needed treatment strategies and along with
MRI assess treatment response. Novel inhibitors will be evaluated for targeting key downstream JAK-activated
pathways including MAPK and PI3K. Our recently developed compound (LP-182) simultaneously targeted these
pathways and MRI was found to detect marrow treatment responses in MF mouse models including a reduction
in fibrosis along with improved survival. This integrated, multidisciplinary approach is poised to advance an MRI
companion diagnostic for MF patients in tandem with reducing cancer-related mortality to improve outcomes.

Public health relevance
PROJECT NARRATIVE Management of patients with myelofibrosis (MF) is hampered by lack of imaging readouts of bone marrow disease involvement and approved targeted agents against JAK2. As activation of the MAPK/PI3K/mTOR signaling pathways are involved with MF disease progression, this project will progress new targeted treatments and next-generation strategies for MF treatment in tandem with development of MRI biomarkers for detection of bone marrow disease progression and treatment response.